Administrative Core A

Core A: Administrative
ABSTRACT
The Administrative Core (Core A) is the engine behind the innovative, impactful research enterprise of Penn
CFAR, a collaboration of the University of Pennsylvania, Children’s Hospital of Philadelphia (CHOP) and
the Wistar Institute. Core A drives CFAR strategic planning, provides scientific leadership to implement new
research directions, and oversees the establishment and activities of its Scientific Working Groups (SWGs),
Shared Resource Cores, Developmental Core, educational, mentoring & partnering activities, and initiatives to
advance ties to campus, community, and regional, national & international partners. Core A provides campus
leadership, ensuring institutional support, prioritization for AIDS research and recruitment, outreach to develop
new partnerships, and communication to maintain a collaborative, interactive scientific community. Core A is led
by Drs. Ronald Collman (Director), Robert Gross (Co-Director), and Kathleen Brady (Core Investigator) of
the Philadelphia Department of Public Health. Core A works closely with a governing Executive Committee,
an External Advisory Committee, an Internal Advisory Board, and Community Advisory Board.
Strategic priorities in the current cycle led to a vibrant new partnership with the Philadelphia Department of
Public Health (PDPH), developing new domains including implementation science and tissue reservoir
research, nurturing a new generation of AIDS investigators & leaders, and expanding diversity within the
CFAR community & leadership. CFAR investigators have made high impact discoveries in AIDS priority areas
including HIV reservoirs, immune control & cure; platforms & novel models for vaccines; HIV comorbidities; social
determinants of HIV health; engagement in prevention & care; and other key topics. For this next cycle, oversight
& evaluation led by Core A resulted in significant changes to the CFAR Cores, SWGs and strategic priorities.
Core A’s aims are to (1) Deploy CFAR activities and resources to galvanize research in current & emerging high
priority areas through SWGs, interdisciplinary collaborations, core activities and developmental projects; (2)
Provide administrative leadership to ensure effective communication among CFAR components and members,
lead a robust and inclusive strategic planning process, secure institutional resources, and recruit outstanding
AIDS researchers to campus; (3) Oversee CFAR Shared Resource Cores to ensure that they enhance research
capacity, serve the needs of CFAR investigators, introduce new enabling technology that advances the research
agenda, and support SWGs; (4) Ensure sound fiscal management of CFAR Cores, developmental funds and
institutional resources; (5) Establish and oversee multidisciplinary educational, mentoring and outreach activities
that engage and advance the scientific development of trainees and junior faculty, create partnerships to bring
non-AIDS investigators into the field, and promote diversity & inclusion in CFAR, and; (6) Ensure that CFAR is
fully engaged with communities affected by HIV, regional partners, PDPH, leverages and contributes to the Inter-
CFAR network, and spearheads robust collaborations & capacity building activities with international partners.